Molecular Mechanisms in Gastrointestinal Stromal Tumor

ABSTRACT
Gastrointestinal stromal tumor (GIST) is the most common human sarcoma and typically arises from the
stomach or small intestine. The cancer generally has a single mutation, either in KIT or PDGFRA. Imatinib
and other tyrosine kinase inhibitors that attack the oncoproteins associated with these mutated genes are
effective, but resistance develops around 18 months and cure is rare. There are no other effective
treatments so new therapeutic approaches are needed. Over the last 13 years, we have extensively
studied the immune response to GIST in a genetically engineered “knockin” mouse model and over 300
fresh human GIST surgical specimens. To investigate the antitumor immune response in greater depth,
we have just performed single-cell RNA sequencing on over 50,000 intratumoral immune cells from tumors
of mice that were treated with vehicle or imatinib. We discovered that gdT cells are enriched in the tumor
compared with blood and spleen. We have preliminary data that gdT cells suppress GIST growth in vivo,
at least in part due to IL-17 secretion. Furthermore, imatinib therapy enhanced their IL-17 production. We
also found that gdT cells infiltrate human GIST and they produce IL-17, similar to the mouse model. The
importance of gdT cells in human GIST, or any sarcoma for that matter, is unknown. We have preliminary
data that the presence of gdT cells correlates positively with overall survival in GIST patients. We
hypothesize that gdT cells play a critical role in the antitumor immune response to GIST and can be
manipulated for therapeutic efficacy. In this proposal, we will investigate the importance of gdT cells in
mouse and human GIST by first defining the mechanism of gdT cell suppression of murine GIST. Next, we
will determine how imatinib affects intratumoral gdT cells in murine GIST. Interestingly, unsupervised
clustering of the single-cell RNA expression revealed 2 main subsets of intratumoral gdT cells in our mouse
model. We will study their different function. We will establish the translational relevance of gdT cells in
GIST. We will test several gdT cell activating agents in combination with imatinib in our mouse model.
Furthermore, we will study the function of gdT cells isolated from fresh human GIST surgical specimens
and correlate their presence to clinicopathologic variables and immune infiltrate. Lastly, we propose to
perform scRNAseq on intratumoral immune cells from fresh human GISTs. Our single-cell RNA
sequencing data have given us an unprecedented look into the complexity of the immune response to
GIST and have formed the basis for numerous hypotheses in this proposal. While we are focused on GIST,
we expect that our findings will have relevance to gdT cells in other human cancers.

Public health relevance
NARRATIVE We propose to investigate the role of a particular type of immune cell that infiltrates a gastrointestinal cancer. We will define its biology, understand how it is altered by tumor therapy, and activate it for anti- tumor efficacy. The findings may lead to novel approaches to treat patients with cancer.